Advancing breast cancer risk prediction in national cohorts: the role of mammogram-based deep learning

To date, significant efforts devoted to developing breast cancer risk prediction models that produce modest
discriminatory accuracy in the range of 59-68% and underperform in Black women compared to non-Hispanic
white (NHW) women, limiting their clinical impact on equitable precision-based/personalized breast cancer
prevention and screening. Emerging data suggest that deep learning (DL) models based on mammographic
images outperform traditional breast cancer risk prediction models based on clinical and risk factors and breast
density alone. Yet there remain major gaps to resolve before widespread roll out of DL methods in order to
enhance outcomes and reduce health disparities in breast cancer. These models have been developed in
clinical or screening cohorts and require further validation in “real world” settings. Equally unknown is how
performance of MDL risk models may differ between Black and NHW women, as few previous studies included
sufficient numbers of Black women for meaningful interpretation. Finally, the combination of polygenic risk
scores (PRS) and MDL risk scores could significantly improve clinical utility of these risk stratification tools, yet
MDL and PRS clinical rollout are largely being evaluated separately, primarily due to lack of availability of both
mammographic and genetic data in the same study population. We propose to leverage existing unparalleled
resources from two complementary national cohorts, the Sister Study and the Black Women’s Health Study,
with digital screening mammograms, genomic data, and extensive epidemiologic and clinical data to address
these evidence gaps (ncases, 971; ncontrols, 8793). In Aim 1, we will validate the performance and clinical risk
stratification of Mirai, a published MDL model with the highest accuracy in screening cohorts to date, in our
epidemiologic cohorts. In addition to considering breast cancer risk overall, we will evaluate performance of
this MDL model for early and advanced stage and for ER+ and ER– breast cancer, outcomes with significant
clinical implications for prognosis and treatment. In Aim 2, we will evaluate the addition of PRS to MDL risk
scores in improving risk stratification, and determine net reclassification. In Aim 3, we will determine whether
MDL models perform equally well and impacts risk stratification within strata of breast density, as defined in
widespread implementation of breast density notification legislation (dense vs. non-dense). These results may
provide crucial data for guiding follow up and surveillance of women with and without dense breasts. To ensure
equitable application of results, we will examine differences in results between Black and NHW women in all
aims. MDL models hold great promise as breast cancer risk assessment tools, and offer clinical efficiency and
optimization by eliminating the need to collect detailed family history and risk factor data. Validation in “real
world” epidemiologic cohorts will advance the field substantially. The research proposed here has great
potential to identify women at both high and low risk of breast cancer, inform personalized screening and risk
reduction strategies, and even to reduce racial disparities in breast cancer outcomes.

Public health relevance
The overarching goals of this research are to validate and improve personalized breast cancer risk assessment tools leveraging extensive mammographic, genetic, and epidemiologic/clinical data from large national cohorts, the Black Women’s Health Study and the Sister Study. We will apply methods in deep learning to mammographic images along with recent genetic risk assessment approaches to advance precise risk stratification while addressing critical gaps in the current evidence base. Findings from this study will inform screening and risk reduction strategies and ultimately help close the gap in racial disparities in breast cancer.